Role of tumor cell cluster-induced signaling in breast cancer metastasis

PROJECT SUMMARY (from parental grant)
The root cause of most breast cancer deaths is metastasis. By dissecting the molecular events driving it, the
research community can develop new therapeutic approaches to eradicate and prevent metastatic disease. One
promising avenue of research involves the cooperative behavior of tumor cells. Conventionally, metastasis is
conceptualized as the dissemination of individual tumor cells to distant organs. However, recent studies by the
Cheung research group and others have established that clusters of tumor cells metastasize to distant organs
more efficiently than single cells in mouse models, and that circulating tumor cell clusters are associated with
poor patient outcomes and therapy resistance in humans. The molecular mechanisms responsible for aggression
in tumor cell clusters and the optimal therapeutic strategies to eliminate clusters have remained obscure.
Recently, the Cheung laboratory has found that clustered tumor cells display heightened levels of apoptosis
resistance, cell proliferation, and changes in molecular expression that indicate that the cells are cooperating
with one another. These studies reveal that the tyrosine kinase EGFR is activated at cell-cell contacts in clustered
tumor cells, and they establish that EGFR and the low-affinity EGFR ligand Epigen are necessary for cluster-
dependent proliferation and metastatic colonization. The proposed project will test the hypothesis that tumor cell
clusters are highly metastatic because they contain a private signaling environment involving EGFR, Epigen,
and the transcription factor Fra-1, and that disrupting this signaling environment will neutralize clusters’
metastatic potential. The Cheung lab has already developed technically innovative organoid and murine models
to study cluster-based signaling and its impact on metastasis in vivo. Using these models, the lab will first
determine whether cluster-induced metastatic efficiency depends specifically on local activation by Epigen.
Second, the lab will determine the impact of Fra-1 transcriptional programs and signaling feedback loops on
metastatic processes specific to tumor cell clusters, as well as whether this program depends on the presence
of Epigen. Third, the lab will supplement its experimental findings by studying the association between EGFR,
Epigen, and long-term recurrence and mortality data from human breast cancer datasets. Through this integrated
approach, the Cheung lab will develop an understanding of the cooperative molecular mechanisms that underlie
the propensity of tumor cell clusters to metastasize. As described in the proposal, this understanding is likely to
reveal molecular vulnerabilities that can be exploited to develop new anti-metastatic therapies. Although the work
proposed here focuses on uncovering therapeutic strategies to target tumor cell clusters in breast cancer, the
findings will potentially be relevant to a wide range of tumor types.

Public health relevance
PROJECT NARRATIVE (from parental grant) The ultimate cause of most breast cancer-related deaths is metastasis, the spread of cancer to distant organs. Recent research indicates that in breast cancer, as well as many other tumor types, circulating clusters of tumor cells are associated with therapy resistance, widespread metastases, and significantly worse prognosis. By learning more about these micrometastases, this proposal seeks to identify molecular vulnerabilities that can be used to eradicate them, thereby extending survival in patients with metastatic breast cancer.